Implementing Evidence-Based Treatment for Common Mental Disorders in HIV Clinics in Ukraine

PROJECT SUMMARY
From 2010-2020, Eastern Europe reported a 72% increase in new adult HIV infections, representing the
highest rate of increase globally. Among the Eastern European countries, the HIV epidemic in Ukraine is one
of the largest, with nearly 260,000 people with HIV (PWH). Nevertheless, in 2020, only 54% of Ukrainian PWH
were on antiretroviral therapy (ART), and only 51% were virally suppressed. These suboptimal HIV care
continuum outcomes are partially attributable to mental disorders, which are more prevalent among PWH
generally (and in Ukraine specifically) and have been linked to decreased ART adherence and poor
engagement in HIV care. To minimize the adverse effects of impaired mental health on HIV outcomes, creating
a pathway to increase access to evidence-based mental health care is a critical public health need. The long-
term goal of this applicant is to develop expertise in testing transdiagnostic mental health interventions to
improve HIV outcomes among PWH in Ukraine. The objective of this K23 application is to adapt the Common
Elements Treatment Approach (CETA), by incorporating the single-session Life Steps ART adherence
intervention, to reduce symptoms of depression, anxiety, and posttraumatic stress among PWH in Ukraine.
The central hypothesis to be tested is that the adapted CETA plus Life-Steps intervention will improve both HIV
and mental health outcomes among PWH in Ukraine. The strong preliminary data supporting this application
shows that community psychologists in Ukraine feel they do not have adequate knowledge to deliver mental
health treatment but nonetheless have strong interest in learning short-term treatments such as CETA. To test
the central hypothesis, the following specific aims are proposed: (1) To define relevant clinical and contextual
factors for adapting CETA for delivery in HIV clinics and for integrating Life-Steps into the existing protocol; (2)
To determine the feasibility, acceptability, and preliminary efficacy of the adapted CETA plus Life-Steps
intervention; and (3) To estimate potential mediators and moderators of the adapted CETA plus Life-Steps
intervention. The expected outcome of this K23 is that this applicant will gain the expertise needed in the three
critical training areas of HIV and mental health, design of randomized clinical trials, and longitudinal data
analysis necessary to achieve research independence. The key innovation is that this study will be the first to
combine CETA with Life-Steps and evaluate its preliminary efficacy in a low- or middle-income country setting.
The resulting preliminary data will also support a compelling R01 application, to be submitted in year 4 of the
K23 award period, to test the adapted CETA plus Life-Steps intervention in a fully-powered, multi-site efficacy
study in Ukraine. If successful, the proposed research will have significant public health impact by providing an
evidence-based intervention for treating mental health problems among PWH, with attendant implications for
addressing the dual mental health crisis and HIV epidemic in PWH populations throughout Eastern Europe.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it is aimed at informing methods of increasing access to quality mental healthcare among people with HIV, which is hypothesized to improve both mental health and HIV outcomes. The findings are expected to enhance HIV treatment efforts in under-resourced settings worldwide. The proposed research is directly relevant to NIH HIV/AIDS Research Priorities on addressing HIV-associated comorbidities, including mental illness, as well as with its strategic goal of improving treatment outcomes among persons with HIV.